Affect regulation and Beta Amyloid: Maturational Factors in Aging and Age-Related Pathology

PROJECT SUMMARY Per the FOA, this document is not required.

Public health relevance
PROJECT NARRATIVE Per the FOA, this document is not required.